Bronx-Einstein Training in Teaching and Research (BETTR), an IRACDA program

Abstract
Hispanics are the fastest growing segment of the U.S. population and yet they are
underrepresented at all levels in the scientific community. According to the 2013 Census, 54.6%
of the population of the Bronx was of Hispanic, Latino, or Spanish origin. The Bronx-Einstein
Training in Teaching and Research (BETTR) program is a four-year post-doctoral scholars
program, which couples training in independent research with training in innovative teaching
techniques and the experience in and guidance for hands-on teaching. Three years are funded
by the IRACDA program, and one year by the research mentor sources or through other non-
IRACDA sources. Traditional training in research methodologies will be based at Einstein, and
mentored teaching training will take place at two neighboring partner institutions in the Bronx,
each Hispanic-serving and both part of the City University of New York (CUNY). Our scholars
will experience a diverse educational experience through mentored training at these two
different types of undergraduate institutions: Hostos, a two year Community College, and
Lehman College, a large four-year undergraduate college. In year one of the BETTR program,
scholars will be immersed at Einstein establishing their research project in the laboratory of their
research mentor. During the second year, scholars will take a pedagogy course and have a
formal shadowing experience at both Hostos and Lehman. During the third and fourth years in
the program, scholars will develop teaching skills at both of our partner institutions while
developing curricula, and experimenting with different teaching strategies. Scholars will work to
achieve research excellence by actively pursuing their own research projects, presenting at
scientific conferences, and attending research-focused workshops, all of which culminate in the
submission of a career development grant application. Scholars will share their research
expertise at Hostos and Lehman through mentoring undergraduate students. In parallel,
scholars are expected to gain teaching skills aligned with the learning styles of minority
populations at urban settings. Additional events, such as Research Days at Hostos and Lehman
and research collaborations among the faculty at all three institutions, will provide research
opportunities for both students and faculty. The goals of the BETTR program are to enhance the
research collaboration culture with our partner institutions, enable our partners to revitalize their
science curricula, provide our scholars with experience and expertise as scientist/educators,
and, thereby, encourage underrepresented minorities to pursue science careers.

Public health relevance
While Hispanics are the fastest growing segment of the U.S. population, they are significantly underrepresented at all levels in the scientific community. This proposal is designed to increase the numbers of underrepresented minorities into academic science by promoting the career development of postdoctoral scholars as science researchers and educators through a partnership between Einstein as a research-intensive institution and Hostos Community College and Lehman College, both Hispanic-serving teaching institutions. The activities of this program and of postdoctoral scholar scientist/educators supported by the program will increase the pool of capable undergraduates interested in research at the partner institutions. Ultimately, it is expected that this program will enhance the numbers of underrepresented minorities in academic science, who will, in turn, contribute research findings of benefit to the health and welfare of diverse US citizenry.